local circuits in the olfactory bulb

A central question in neuroscience is how sensory stimuli in the environment are represented. The
olfactory system is an attractive sensory modality to approach this question since the major excitatory
pathways that connect receptor neurons, second-order mitral cells in the olfactory bulb, and tertiary
neurons in olfactory cortex are well understood. However, intracellular recordings demonstrate that
neural representations of odors in second-order neurons (mitral and tufted cells) do not result
exclusively from feedforward input from receptor cells. Instead, the output of the olfactory bulb results
from complex interactions between excitatory and inhibitory circuits. Relatively little is known about the
neural circuits that generate inhibition onto principal cells. This proposal uses rodent brain slice
recording methods to determine how local circuit pathways excite GABAergic olfactory bulb
interneurons that shape the firing patterns in principal cells. Using both whole-cell intracellular
recording and live 2-photon imaging methods, we will determine how the key synaptic pathways that
enable sensory input to excite granule cells function. The proposed study will test the hypothesis that
GABAergic granule cells are excited by two parallel synaptic pathways activated by sensory stimuli.
This work also will define the different roles played by this newly discovered circuit and well-established
dendrodendritic excitation. The proposed work also will reveal how bulbar local circuits enable
glomerular-specific inhibitory coding in mitral and tufted cells. Defining the cellular mechanisms that
generate sensory-evoked inhibition in the olfactory bulb, the overall focus of this proposal, is critical to
understand how biological information is represented in the brain. The proposed studies also are
significant as they represent an important step toward understanding the specific deficits in many major
neurodegenerative diseases in which olfactory function is affected. In many of these diseases, sensory
impairments occur early in the disease onset. Insights into the specific olfactory mechanisms affected
in these diseases may lead to directly testable hypotheses regarding analogous mechanisms in the
cortical areas responsible for the cognitive deficits commonly associated with neurodegenerative
disorders.

Public health relevance
Public Health Relevance One of the fundamental questions in neuroscience is how activity of brain cells represents stimuli in the environment. The proposed research program seeks to define fundamental aspects of how olfactory stimuli are processed by the olfactory bulb, the primary olfactory brain region. Since olfaction is often impaired early in the course of neurodegenerative diseases, our work may lead to new insights into the core circuit functions affected in these conditions.